Mechanoregulation of EHEC virulence

PROJECT SUMMARY
Environmental sensing is at the basis of an organism's ability to adapt its physiology to respond to changes in
its niche. Over the past years, it has emerged that bacteria not only perceive and respond to chemical stimuli,
but are capable of sensing and processing physical forces as an environmental cue. In the case of bacterial
pathogens, we and others have shown that mechanical stimuli can act as a hallmark of host colonization and
lead to activation of virulence genes. Despite this realisation, our mechanistic understanding of pathways and
systems involved in mechanosensing, transduction and processing of physical forces is currently limited, as is
our knowledge regarding the role of mechanoregulation within the host environment. Over the course of this
grant, we have made important discoveries regarding the mechanistic basis of mechanoregulation in the human
pathogen enterohemorrhagic E. coli (EHEC). In the human host, ingestion of EHEC can lead to enterocolitis and
severe complications such as haemolytic uremic syndrome. These hallmarks of infection are caused by the
concerted action of virulence factors, including colonization factors and Shiga toxins. We discovered that the
transcriptional regulator GrlA regulates the LEE pathogenicity island encoded type 3 secretion system, an
important colonization factor, in response to mechanical cues. We showed that GrlA is regulated by subcellular
compartmentalisation, and is sequestered on the inner membrane in resting cells. When activated by shear force
GrlA dissociates from the membrane and is released into the cytoplasm, where it binds and induces the LEE
masterregulator Ler. We also showed the biochemical basis for this mechanism, by identifying both constitutively
active GrlA variants, and variants that are `blind' to mechanical cues. Regarding the interplay between intestinal
motility and EHEC infection, we have identified Shiga toxin 2 as an effector that leads to enteric nervous system
stimulation and increased gut transit. We discovered that the Shiga toxin 2-converting phage, but not Shiga toxin
1 is also subject to mechanical induction via GrlA. In this competing renewal application, we will (1) determine
the mechanistic basis for the observed mechanoregulation of Shiga toxin and the toxin encoding phage, (2)
characterize Shiga toxin induction in vivo and its impact on gastrointestinal motility, and (3) define the role of
Shiga toxin during competition of EHEC with the endogenous microbiota. This work will reveal an alternative
regulatory mechanism for a phage-encoded toxin, and define the role of Shiga toxin during bacterial colonization
and inter-species competition in the host niche.
.

Public health relevance
PROJECT NARRATIVE During the previous grant period, we discovered how the human pathogen enterohemorrhagic Escherichia coli responds to mechanical cues in its environment by subcellular compartmentalisation of the transcriptional regulator GrlA, and showed the mechanistic basis of GrlA shuttling between inner membrane and cytoplasm in resting versus mechanically stimulated cells. The experiments described in this application will determine how another key EHEC virulence factor, Shiga toxin, is regulated by mechanical cues, and how the toxin facilitates EHEC colonization by modulating gut motility and displacement of the endogenous microbiota. This work will reveal a new regulatory mechanism for Shiga toxin-converting phage, and provide new insights as to the role of the toxin during host colonization.